Role of tRXRalpha in pancreatic cancer development and therapy

DESCRIPTION (provided by applicant): Pancreatic cancer is a devastating disease. It ranks the fourth cause in cancer-related death in western countries. In its 2012 Cancer Facts & Figures report, American Cancer Society estimated that 43,920 new cases of pancreatic cancer would occur in the US this year. The treatment options for pancreatic cancer remain limited and clinical trials of therapies have not generated much exciting outcome in advanced pancreatic cancer. Thus, there is a strong and urgent need to discover and develop new and effective drugs. To do so, it requires a better understanding of the pancreatic cancer biology, the identification of novel targets and the investigation of the mechanisms of actions of the new targets. Retinoid X receptor-α, RXRα, is a member of the nuclear receptor family and plays an important role in the control of many biological processes including carcinogenesis. Altered expression and function of RXRα is implicated in many cancer diseases such as breast, prostate and lung cancers and a RXRα-targeted drug, Targretin was approved by FDA for treating cutaneous T-cell lymphoma. Recently we discovered that an N-terminally-truncated RXRα (tRXRα) resulted from proteolytic cleavage of RXRα in cancer cells interacted with PI3K in the cytoplasm to mediate the TNFα signaling and that the nonsteroidal anti-inflammatory drug (NSAID) Sulindac could bind to tRXRα to regulate tRXRα-mediated TNFα signaling pathways (Cancer Cell 17, 560, 2010). Interestingly, a previous study showed that tRXRα was highly produced in all cell lines established from 13 patients with pancreatic ductal adenocarcinoma. However, the role of tRXRα in the pancreatic cancer cell growth and drug resistance is unknown. Therefore we hypothesize that tRXRα plays a critical role in the development of pancreatic cancer and the resistance of pancreatic cancer cells to chemotherapy and that tRXRα is a potential target for treating pancreatic cancer. In this proposal of pilot studies we will address these hypotheses by carrying out the following Specific Aims: (1) To study the role of tRXRα in promoting pancreatic cancer cell growth and drug resistance; and (2) To identify the tRXRα surface binding site for drug targeting. Our application, which proposes to determine the role of tRXRα in promoting pancreatic cancer cell growth and drug resistance and to validate a novel drug target, is exploratory and novel. The project is expected to generate new information to lay the foundation for future extensive mechanistic study of the oncogenical potential of tRXRα and drug discovery for pancreatic cancer therapy through R01 funding mechanism.

Public health relevance
The survival time for pancreatic cancer patients are short because no effective drugs are available. The pilot studies proposed in this application seek to determine the role of a truncated retinoid X receptor-α (tRXRα) in promoting pancreatic cancer cell growth and drug resistance and to explore the potential of tRXRα as a candidate drug target for effective pancreatic cancer therapy.